NIA AD/ADRD Health Care Systems Research Collaboratory

Over 6 million Americans live with Alzheimer's disease (AD) or an AD-related dementia (AD/ADRD). Health care
systems (HCS) struggle to provide high quality, coordinated, and equitable care to people living with dementia
(PLWD) and their care partners (CPs). Scalable and adoptable interventions that are effective in improving the
care delivered by HCS to this vulnerable population are desperately needed. Established in September 2019,
the National Institute on Aging (NIA) IMbedded Pragmatic Alzheimer's disease (AD) and AD-Related Dementias
(AD/ADRD) Clinical Trials (IMPACT) Collaboratory mission is to build the nation’s capacity to conduct embedded
pragmatic clinical (ePCTs) of interventions within HCS for PLWD and their CPs. Since its inception, IMPACT has
actualized its original aims to advance the conduct of ePCTs, develop and disseminate knowledge, build
investigator capacity, and catalyze stakeholder collaboration. IMPACT’s accomplishments and challenges over
its initial 5 years inform its next steps and provide rationale for its continuation. A one-year “bridge” supplement
between the current award end date of June 30, 2024 and an anticipated competitive renewal start date is
requested from July 1, 2024 thru June 30, 2025. The objective of the "bridge" is to maintain the essential
administrative services necessary to supervise and support 36 ongoing projects across IMPACT’s five funding
mechanisms (Pilots, Demonstration Projects, Health Care System Scholars, Real World Data Scholars, and
Career Development Awards). The administrative services to be maintained during the “bridge” year include:
tracking project performance, sustaining IMPACT’s knowledge repository and website, monitoring essential
financial functions, maintaining regulatory compliance with the centralized IRB, DSMB, clinical trials.gov, and
CROMs. Additionally, for the Long-Term Care Data Cooperative, created under a COVID related IMPACT
supplemental project, but now serving investigators conducting nursing home based clinical trials, as well as,
observational comparative effectiveness studies, the bridge is essential to keep this initiative operational.
IMPACT: IMPACT’s bold vision is to transform the delivery, quality, and outcomes of care provided to Americans
living with dementia and their CPs by accelerating the testing and adoption of evidence-based interventions
within HCS. Its accomplishments to date provide a strong foundation for this vision, but realizing it will require
more time, investment, and innovative approaches. Support for a bridge year, with an anticipated 5-year renewal
period to follow, is necessary to maintain essential functions for 36 projects in process and the Long-Term Care
Data Cooperative, and ultimately, achieve the full potential of this remarkable national infrastructure and
ultimately translate its resources to meaningful improve in the quality of care delivered to PLWD and their CPs.

Public health relevance
The vision of the National Institute on Aging (NIA) IMbedded Pragmatic Alzheimer's disease (AD) and AD- Related Dementias (AD/ADRD) Clinical Trials (IMPACT) is to transform the delivery, quality, and outcomes of care provided to Americans living with dementia and their care partners by accelerating the testing and adoption of evidence-based interventions within HCS. The proposed work will build on IMPACT’s accomplishments to date and support continued work to achieve the full potential of this remarkable national infrastructure and ultimately translate its resources to meaningful improve in the quality of dementia care.